Molecular mechanisms of synapse loss in Alzheimer’s disease

PROJECT SUMMARY/ABSTRACT
Loss of synapses is the strongest neuropathological correlate for clinical cognitive decline in Alzheimer’s Disease
(AD) patients. In AD mouse models, synapse loss is dependent on neuroinflammatory glial cells and their
phagocytic cell surface receptors, many of have been found to interact with extracellularly exposed
phosphatidylserine (PS). PS is a plasma membrane phospholipid that is maintained on the cytosolic leaflet but
can be flipped to the extracellular leaflet following cellular stress. These interactions led to the hypothesis that
glial synapse removal in AD may require synaptic PS exposure. Recent studies have shown that disruption of
glial receptor-PS interactions ameliorate synapse loss, electrophysiological deficits, and behavioral phenotypes
across several models. While there have been numerous investigations into the mechanisms regulating glial
phagocytic receptors, there has yet to be a systematic investigation into mechanisms regulating synaptic PS
exposure. I have developed a novel pooled CRISPRi screening platform to systematically elucidate mechanisms
of synaptic PS exposure. This initial screen has revealed potential roles for IL-6 and IL-11 signaling in regulating
synaptic PS exposure. In my first aim, I propose to determine how the IL-6 and IL-11 signaling pathways
differentially affect synaptic PS exposure, glial synaptic engulfment, and in vivo synaptic function both at baseline
and within AD model systems using a combination of pharmacological, genetic, and electrophysiological
approaches. In my second aim, I propose to identify other novel genetic regulatory mechanisms of synaptic PS
exposure in AD. To do this, I will expand my initial functional genomics screen to cover the entire protein-coding
genome and conduct differential phosphoproteomic analysis on synapses exposing high and low levels of PS
both at baseline and within the context of an in vitro AD model. Finally, I will validate these newly discovered
regulators using similar pharmacological, genetic, and electrophysiological approaches as I propose to use in
my first aim. Finally, I will study how these validated pathways are differentially expressed within AD patient
brains using immunohistochemical techniques. My sponsor, Dr. Martin Kampmann, who co-developed the
CRISPRi screening technology, and my cosponsor, Dr. Robert Edwards, who is a physician-scientist and an
expert in synaptic biology and neurotransmitter release, are ideally positioned to support my proposed research.
In addition to my two sponsors, I will also receive clinical mentorship from Dr. Bruce Miller, a behavioral
neurologist who specializes and the diagnosis and management of neurodegenerative diseases with a particular
focus on AD and other tauopathies. Overall, the proposed work will uncover novel mechanisms regulating an
understudied aspect of AD pathophysiology and identify new therapeutic targets for the treatment of AD.
Furthermore, this work will provide me with essential expertise for my future as a physician-scientist studying the
intersection of neurodegeneration and synaptic dysfunction.

Public health relevance
PROJECT NARRATIVE Loss of synapses is the strongest neuropathological correlate of cognitive decline in Alzheimer’s disease (AD) patients, yet the mechanisms that drive specific synapses to be eliminated and others spared are not fully understood. The goal of this proposal is to (1) elucidate the molecular mechanisms that regulate synaptic exposure of phosphatidylserine, a molecule that has been previously shown to drive synapse loss in AD, (2) determine how these pathways influence glial synaptic uptake and in vivo synaptic function, and (3) measure activity of these pathways within AD patient brain tissue. Completion of this proposal has the potential to identify novel therapeutic targets regulating synapse loss in AD enabling the development of drugs that can potentially stymie and reverse cognitive decline in AD patients.